Translational assessment of an FAK inhibitor for acute cerebroprotection

Summary. We have shown that a pharmacological FAK inhibition and astrocyte FAK deletion are
cerebroprotective after ischemic MCAO stroke in female, but not male, mice. A systemic small molecule FAK
inhibitor treatment was efficacious when started 6 h after reperfusion following an MCAO, as shown by motor
function and histological analyses of the injury site. We propose the FAK inhibitor or one in clinical trials for
cancer as a candidate for preclinical assessment by the SPAN test sites, including replication in young adult
mice, in aged mice, in rats and animals with comorbidities. This finding is based on work over more than ten
years in our lab after we discovered a new integrin-FAK-STAT3 signaling pathway that regulates cytokine
expression. In female mice, plasma vitronectin (VTN) that leaks into the brain injury activates integrins to
exacerbate the progressive injury over the first two days which is mediated in large part by acute pro-
inflammatory IL-6 expression in the brain. Stroke induced plasma VTN levels in females only and the levels
correlate with worse tissue injury. The VTN-induced IL-6 mechanism was not affected by ovariectomy
suggesting that sex hormones are not involved. Using cre-lox mice, we identified astroglial FAK as the major
driver of the detrimental IL-6 peak in female, but not male, mice. Moreover, FAK14 was cerebroprotective in
WT females but not in VTN-/- female littermates or in males. Thus, we have identified a pleiotropic mechanism
that can be inhibited by a drug downstream of a detrimental blood protein and irrespective of its levels. In Aim
1, the Hagg lab will determine a dose-response curve in mice for the two FAK inhibitors to define the lowest
dose that has maximal efficacy, and their potency. Outcome measures will be FAK phosphorylation and
cytokine expression in brain tissue at 24 h after intraluminal filament MCAO with reperfusion and for reducing
functional deficits and brain injury size at 7 d. The test sites would receive the most promising of the two
inhibitors after quality control for the compounds we receive from suppliers. For Aim 2a, the test sites would
replicate our finding that the FAK inhibitor is cerebroprotective after MCAO in young adult C57BL/6J females
and not males. Outcome measures are injury size, as measured by repeated MRI, and sensorimotor function
tests over 30 days, as defined by the current SPAN. Aim 2b would test it in aged mice and Aim 2c in young
adult rats. Depending on the outcome, mouse or rat models of the most common risk factor comorbidities of
human stroke, hypertension and diabetes, will be tested in Aim 2d. To broaden the potential clinical impact,
Aim 2e will test the FAK inhibitor in a clot-tPA reperfusion model. In Aim 3, our lab will determine whether high
VTN levels caused by comorbidities are a risk factor for worse stroke outcomes by analyzing plasma and
brains from test site rodents. We also expect the risk to be reduced by the FAK inhibitor. Key milestones will
be the selection of the FAK inhibitor and its dosing, replication and weighing its potential clinical promise in
light of showing cerebroprotective effects in different models tested by the testing sites. If successful, we will
contribute a new intervention which targets a specific mechanism and is well-tolerated, for clinical stroke trials.

Public health relevance
Project Narrative This grant will preclinically assess, within a well-organized NINDS-supported network of leading stroke labs, whether FAK inhibitors can reduce neurological deficits and brain injury, measured by repeated MRI, after ischemic stroke. The lead inhibitor will be tested in young and aged female and male mice, in rats, and in animals mimicking human stroke comorbidities of hypertension and diabetes. We expect to identify a new treatment to maximize tissue protection and function as adjuvants of standard-of-care reperfusion treatments for subsequent testing in clinical stroke trials.